Automating Quality to Accelerate Transformational Improvements in Care (AQUATIC)

Abstract
Current methods for evaluating quality measures are time-consuming, costly, and often delayed,
limiting the effectiveness of timely quality improvement (QI) initiatives. Typically, quality performance
assessments are restricted to small patient samples evaluated months after discharge, resulting in
inconsistent and statistically underpowered data. This lag hampers the ability to use insights for
immediate feedback and improvement. To overcome these limitations, we have developed QuaLLM,
an innovative automated toolset that allows real-time abstraction and evaluation of quality measures.
QuaLLM enables key stakeholders to assess quality and the effectiveness of improvement-oriented
changes in near real-time, with greater efficiency. Our approach leverages Fast Healthcare
Interoperability Resources (FHIR) to enable seamless electronic health record (EHR) data exchange
and generative artificial intelligence (GenAI), specifically large language models (LLMs), to automate
clinical quality reporting. The proposed work aims to develop a foundational model for quality
measure abstraction that is easily adaptable to new measures. We will prospectively validate
QuaLLM against existing reports generated within a large academic health system using a variety
of infection related measures that are reported to CMS. This proposal seeks to revolutionize
healthcare QI by replacing the traditionally manual, resource-intensive abstraction process with a
real-time, AI-driven solution. The successful implementation of this project could lead to enhanced
patient outcomes through timely insights into quality performance, substantial reductions in
healthcare costs, and the establishment of a more agile and responsive learning healthcare system.

Public health relevance
Narrative This proposal centers on the development of QuaLLM, an AI-driven tool designed to automate the evaluation of healthcare quality measures in near real-time. By harnessing electronic health records and leveraging interoperability standards, QuaLLM provides timely insights and efficient quality reporting, empowering healthcare systems to continuously monitor and enhance patient care. The successful implementation of this initiative will offer a validated tool that enables healthcare providers to efficiently optimize care delivery, ensuring the best outcomes for patients